Cholinergic interneuron D2 receptor function in impulsive behavior: implications for addiction

Project Summary
Chronic cocaine abuse is associated with long-lasting impairments in impulse control and decision-making that
increase the risk for relapse. However, the brain circuits fundamentally involved in impulsive behavior and their
alteration by chronic drug use are not well understood. Accumulating evidence in humans and animals implicates
nucleus accumbens (NAc) dopamine D2 receptors (D2Rs), yet given their wide expression in different neuronal
populations, it remains unclear which D2Rs play a key role in impulsive behavior. In particular, the contributions
of D2Rs in cholinergic interneurons (CINs), which constitute only 2-3% of neurons in the NAc, have been largely
overlooked, despite known CIN contributions to NAc function and cocaine reinforcement. To fill this gap in our
knowledge, it is urgent to elucidate the consequences of D2R alterations in CINs on impulsive behavior with
greater cell-type specificity. Our long-term goal is to elucidate the cellular and circuit mechanisms by which NAc
CINs regulate impulsive behavior, which may uncover potential therapeutic strategies for reducing cocaine re-
lapse. The overall objective of this application is to use cell-selective strategies to: 1) determine whether and
how CIN D2Rs mediate impulsive behavior, and 2) whether CIN D2Rs participate in cocaine-induced augmen-
tation of impulsivity. Our central hypothesis is that CIN D2Rs mediate impulsive behaviors by altering NAc ace-
tylcholine (ACh) release following predictive cues, and that chronic cocaine causes excessive impulsivity via CIN
D2Rs. Aim 1 will use cell type-specific genetic approaches in mice to bidirectionally alter D2R expression in CINs
to test the impact on a delay discounting task, which assesses preference for small, short-term rewards over
larger, delayed rewards. Using in vivo fiber photometry combined with optogenetics, Aim 2 will determine ACh
dynamics in delay discounting and test whether the ACh pause in response to cues modulates impulsive choice.
Aim 3 will determine whether CIN D2Rs and the CIN pause mediate the increase in impulsive choice resulting
from chronic cocaine exposure. The research proposed in this application is innovative because it uses targeted
approaches in behaving mice to examine a previously unrecognized role for the NAc CIN and its D2Rs in impul-
sivity. Successful completion of the proposed aims will thus generate a novel dissection of neuronal mechanisms
at play in impulsive choice, both under normal conditions and following repeated cocaine exposure. Such infor-
mation is urgently needed for developing new treatments to counter drug-induced alterations in brain function
that contribute to relapse.

Public health relevance
Project Narrative Excessive impulsivity, a hallmark of chronic drug abuse, promotes selection of short-term gains at the expense of long-term goals, like abstaining from drug use or seeking treatment. Developing new solutions to ameliorate drug relapse, therefore, will require a more complete understanding of the brain processes behind impulsive decision making. Here, we will use innovative cell-targeted strategies to uncover the unique roles of cholinergic interneuron D2 dopamine receptors in shaping neuronal signaling and impulsive behavior both in health and after chronic cocaine exposure.